Deciphering the functional role of actin-spectrin-based membrane skeleton in subcellular compartmentalization of signaling proteins and cell signal transduction

Project Summary/Abstract:
Receptor tyrosine kinases (RTKs), G-protein-coupled receptors (GPCRs), and cell adhesion
molecules (CAMs) are three major families of cell surface proteins in all eukaryotic cells, and
together represent the primary first responders for cells to respond an extracellular stimulus and
initiates a variety of signaling pathways to subsequently regulate cell proliferation and
differentiation, promote cell survival, and modulate cellular metabolism and cell-to-cell
communication. Mutations affecting these signaling pathways result in many human syndromes
and diseases, such as various types of neurodegenerative disorders and cancer. The clinical
importance of these signaling proteins has motivated the development of targeted therapies
designed to block the activation of the membrane receptors and the downstream signal
transduction. Increasing evidence has suggested that there is significant signaling crosstalk
between these three membrane protein families at the plasma membrane level and these proteins
can form highly organized membrane micro- or nano-clusters with unique biochemical and
biophysical properties, dictating the signaling outcome. However, the molecular mechanisms by
which how such crosstalk and compartmentalization of membrane-associated signaling proteins
are initiated to modulate the sensitivity and specificity of the downstream signaling remain largely
elusive. Our recent discovery of a newly identified actin-spectrin-based membrane-associated
periodic skeleton (MPS) structure being a signaling platform for RTK transactivation by GPCRs
and CAMs in neurons provides molecular insights into how the cooperative action among these
cell surface proteins can be coordinated to give rise to the downstream signaling. The objective
of this proposal is to combine super-resolution imaging, cell and molecular biology tools, and
mass spectrometry analyses, to investigate the detailed molecular mechanisms responsible for
the MPS-mediated cell signaling, by identifying the key molecular interactions responsible for the
MPS-dependent initiation of the signaling protein clustering (i.e., complex formation) and
examining the roles of liquid-liquid phase separation, receptor endocytosis, and contact sites
between the plasma membrane and intracellular membrane-bound intracellular organelles in the
MPS-mediated signaling. Our proposed research will not only broaden our fundamental
understanding of cell signal transduction controlled by the membrane skeleton and the phase
separation behaviors of signaling proteins, but also help suggest new drug targets for human
diseases including neurodegenerative diseases and cancer.

Public health relevance
Project Narrative: While membrane proteins are important, constituting ~23% of the human proteome and more than 60% of current drug targets, little is known about how the cooperative action among different types of membrane proteins can be coordinated at the cell surface to precisely control the sensitivity and specificity of the downstream signaling. Our recent discovery has revealed a novel molecular mechanism by which a recently discovered spectrin-actin-based membrane skeleton structure can coordinate the interactions among major types of membrane receptors in neurons, giving rise to the downstream intracellular signaling. The goal of this proposed research is to reveal the distinctively physical molecular mechanisms by which this spectrin-actin-based membrane skeleton brings the selected groups of membrane proteins in proximity to form signaling protein complexes at the cell surface, and the results from the proposed research will not only deepen our understanding of how the subcellular compartmentalization of signaling proteins can be spatiotemporally controlled to dictate a specific signaling outcome, but also potentially inspire new strategies for the therapeutic intervention of human diseases.